Increasing Diversity of the Genomics Workforce Through Accessible Data and Visualization

Project Summary
Despite eﬀorts to increase diversity and inclusion, opportunities in genomics education and research are still
unequally oﬀered to people with disabilities. While making data and visualization resources accessible and
useful is vital in genomics education, research, and clinical se ings, genomics resources such as data portals,
visualizations, and research papers largely fail to meet accessibility standards according to our preliminary
evaluation (96.3% of 2,936 evaluated portals), making essential resources rather inaccessible to people with
visual impairments. My overarching goal is to include disability in the genomics workforce by enhancing the
accessibility of data and visualization resources. This project proposes three speciﬁc aims: (1) conducting
accessibility evaluations of biomedical resources, (2) developing accessible visual and textual representations
for genomics data and novel tools based on them, and (3) implementing accessible graphical user interfaces for
genomics data analysis. I will conduct a series of comprehensive accessibility evaluations of biomedical
resources with input from users. Based on the evaluation results, I will build accessibility guidelines for
biomedical resources and their priorities based on diﬀerent use cases which will complement general
accessibility guidelines. The evaluations will unveil critical aspects of potential improvements and oﬀer
guidance toward accessible biomedical resources. Second, by extending my earlier work on the Gosling
grammar-based genomics data visualization, I will help content creators to build accessible genomics data
tables and visualizations which will oﬀer smart accessibility defaults and out-of-the-box accessibility features.
Based on the extended Gosling, I will develop an assistive toolkit that will automatically generate missing
metadata and reﬁne the structure of web pages to enable viewing currently inaccessible data tables and ﬁgures
in existing web-based genomics resources. Given the complexity and scale of genomics data, user interactions,
such as zooming and panning, are essential techniques for genomics data analysis. However, traditional
mouse-based interactions are largely inaccessible without accurate vision. As the last aim, I propose to design
accessible and intuitive user interactions tailored for genomics visualization, such as keyboard-based
interactions. Building on top of the accessible interactions, I will build an accessibility-friendly graphical user
interface (GUI) platform that enables people with visual impairments to create visualizations and analyze
genomics data. The novel tools I will develop will not only help content creators to eﬃciently and accurately
create accessible visualizations but also enable current and prospective genomics students, researchers, and
clinicians with visual impairments to access, interpret, and analyze genomics data, making data-driven
genomics research more inclusive.

Public health relevance
Project Narrative Despite eﬀorts to increase diversity and inclusion, opportunities in data-driven genomics research are still unequally oﬀered to people with visual impairments. I will identify barriers to accessing genomics data and visualization resources through comprehensive evaluations and will implement novel tools by designing accessible representations, interactions, and interfaces that will complement screen reader and magniﬁer assistive technologies. The developed tools will not only help content creators to eﬃciently and accurately create accessible visualizations but also enable current and prospective genomics students, researchers, and clinicians with visual impairments to access, interpret, and analyze genomics data.